Elucidating the Role of Neural Activity in Midbrain Dopamine Neuron Degeneration

PROJECT SUMMARY/ABSTRACT
Parkinson’s Disease (PD) is a debilitating neurodegenerative disease characterized by the progressive loss of
substantia nigra pars compacta (SNc) dopamine neurons. The reasons for their selective vulnerability and the
mechanisms that drive their degeneration remain unclear. There is mounting evidence that the activity of
energetically-burdened SNc neurons is altered in PD, however the role of neural activity in the susceptibility of
dopamine neurons is poorly understood. Additionally, while dopamine is known to be toxic to neurons that do
not have a means of sequestering or metabolizing it, the role of dopamine itself in the degeneration of dopamine
neurons in PD is not known. To investigate the role of activity in dopamine neuron selective vulnerability, we
have developed novel mouse models in which we can chronically manipulate midbrain dopamine neuron activity
using chemogenetics. With these models, we propose to determine how chronically manipulating activity and
dopamine metabolism within dopamine neurons impacts their susceptibility to degeneration. These experiments
will be the first to directly interrogate the role of neural activity in degeneration in a chronic, minimally-invasive
manner. Furthermore, they will provide insight for future therapeutic strategies to protect dopamine neurons from
degeneration in PD.

Public health relevance
PROJECT NARRATIVE Parkinson’s Disease (PD) is a neurodegenerative disease characterized by the loss of substantia nigra dopamine neurons, but our understanding of how their activity state contributes to their selective vulnerability is lacking. Using novel chemogenetic models to manipulate dopamine neuron activity in combination with mice that have disrupted dopamine storage, this proposal will deeply examine the role and mechanisms of neural activity in dopamine neuron susceptibility to dopamine-induced toxicity. Results from the proposed research will aid in the development of therapies to slow or prevent the loss of dopamine neurons and related motor symptoms in PD.